Administrative Supplement for a Cytosurge FluidFM OMNIUM instrument: The RNA nanomachines of the gene expression machinery dissected at the single molecule level

PROJECT SUMMARY:
This supplement will critically update the instrumentation available for several aspects of the parent R35 MIRA
award, entitled The RNA nanomachines of gene expression dissected at the single molecule level. The most
critical features of the proposed instrumentation, the Cytosurge FluidFM OMNIUM, are its versatility, turnkey
readiness, and ease of use for injecting, sampling and manipulating the content of live mammalian cells. These
features will dramatically facilitate access by the diverse group of postdoctoral fellows, graduate students and
undergraduate students in the PI's group to especially our intracellular single molecule fluorescence microscopy
tools, while also empowering for the first time parallel single live cell transcriptome analyses. The injection
capability of the FluidFM OMNIUM will be critical for upgrading our more difficult, aging single mammalian cell
microinjector for use in the parent grant, soon to be renewed. Our MIRA grant aims to dissect the mechanisms
of the nanoscale RNA machines of gene expression at the single molecule level, so far focusing on bacterial
riboswitches and the yeast spliceosome. Acquisition of the FluidFM OMNIUM will empower us to include the
intracellular miRNA-guided silencing machinery for the renewal. Building on our group's 23-year expertise in
this space, we aim to: 1.) Apply our established mechanistic enzymology approaches to an ever broader set of
RNAs involved in regulating transcription, translation and splicing, seizing the opportunities arising from the
continuing discoveries of new functional RNAs. 2.) Push the limits of our approaches to be able to probe
increasingly complex biological contexts and mechanisms since unexpected discoveries often await where
individual RNA nanomachines interact. In pursuit of these aims, we will address the unifying hypothesis that
dynamic RNA structures are a major determinant of the outcomes of gene expression, as exemplified by the fact
that transient miRNA:mRNA interactions lead to the regulation of protein translation in mammalian cells.
Demonstrating the power of our scientific approach to address this hypothesis, we have developed a suite of
intracellular single particle tracking approaches that depend on microinjecting fluorophore labeled RNAs at
defined time points, which will be uniquely enabled by the FluidFM OMNIUM. To reveal the RNA-guided gene
regulatory processes of the cell, we will mechanistically probe the dynamics of miRNA-guided gene silencing
complexes using a tailored combination of single cell microinjection and intracellular single molecule
fluorescence microscopy. A major bottleneck in these pursuits so far has been the steep learning curve
associated with our microinjection-equipped microscopes that keep new group members from making significant
contributions until they have completed 1-2 years of training. We anticipate that addition of the Cytosurge
FluidFM OMNIUM system to our microscopy arsenal will transform the speed of our progress in intracellular
single particle tracking and functional analysis by introducing an easy-to-use cell microinjection and sampling
instrument that postdocs, graduate and undergraduate students can quickly use independently.

Public health relevance
PROJECT NARRATIVE: Leveraging a portfolio of long-standing expertise at the interface of RNA biology and single molecule biophysics, the Walter group applies advanced mechanistic enzymology approaches to a broad set of RNAs involved in the regulation of transcription, translation and splicing, thus seizing the opportunities that continue to arise from discoveries of new RNA functionalities. In addition, we will push the limits of our single molecule approaches to be able to probe increasingly complex biological contexts and mechanisms in which RNA structure governs the function of the cellular gene expression machinery. The acquisition of the proposed versatile, turnkey, easy-to- use Cytosurge FluidFM OMNIUM system will dramatically increase the throughput of our discovery pipeline, as it will allow beginning postdocs, graduate students and undergraduate students alike to quickly climb the learning curve towards becoming productive group members working on miRNA-guided intracellular gene silencing pathways.